Biochemistry of SAMHD1-mediated innate immunity responses

ABSTRACT
SAMHD1 is a human immune factor that impedes infection of myeloid cells and resting T lymphocytes by HIV-
1. SAMHD1 is a deoxynucleotide triphosphate hydrolase (dNTPase), and the discovery of its anti-retroviral
activity brought to light a novel antiviral mechanism that depends on the enzymatically controlled depletion of
cellular dNTP pools. The ability of immune cells to use dNTP depletion for antiviral defense is puzzling,
because even quiescent and terminally differentiated cells require deoxynucleotides for DNA repair and
mitochondrial biogenesis. SAMHD1 is a key regulator of dNTP concentrations in nonproliferating cells and
better understanding of its enzymatic properties may shed light on the tantalizing relationship between dNTP
metabolism and antiviral immunity. Our recent work revealed that the 'facilitated dNTP depletion' function of
SAMHD1 arises from its allosteric activation mechanism, a two-step process involving tetramer assembly and
subsequent activation. Facilitated dNTP depletion enables regulatory crosstalk between biosynthesis and
depletion of different dNTPs and manifests as more robust depletion of some nucleotides when biosynthesis of
certain others is elevated. We hypothesize that the allosteric regulation of SAMHD1 is a key component to the
cellular decision-making mechanism that controls the switching between multiple discrete states of cellular
dNTP metabolism in nonproliferating immune cells and thus determines whether and when these cells become
non-permissive to HIV infection. In this project we seek to advance our understanding of how allosteric and
posttranslational regulation of SAMHD1 enables distinct states of dNTP metabolism by pursuing two specific
aims. In Aim 1 we will delineate how enzymatic properties of SAMHD1 give rise to the antiviral modalities of
dNTP homeostasis and enable immune and metabolic decision-making. We also seek to establish mechanistic
relationships between the distinct states of cellular dNTP metabolism and the susceptibility to HIV infection. In
Aim 2 we will elucidate the structural basis of allosteric and posttranslational regulation of SAMHD1. Our recent
findings reveal that SAMHD1 activation by dNTP substrates involves an inactive tetrameric intermediate with
partial dNTP occupancy of the allosteric sites. Here we will further elucidate the conformational repertoire of
SAMHD1 activation and how it is modulated by posttranslational modifications, nucleic acid ligands and
pathogenic mutations.

Public health relevance
PROJECT NARRATIVE Restriction factors—cellular proteins whose activity interferes with specific steps in viral replication and protects cells against infection—are important components of innate immunity defenses against viral pathogens. Modulating activity of the host’s restriction factors and/or targeting viral evasion from them is an attractive, albeit largely unexplored, intervention strategy for treatment and/or prevention of viral infections. This proposal is focused on SAMHD1, a protein that impedes HIV-1 infection of non-dividing myeloid cells and resting T cells. The goal of the studies described here is to characterize biochemical properties of SAMHD1 and to understand how the biochemical activity of the protein shapes its anti-retroviral function.